Task Order D14: Preclinical, Microbiological, Safety, Toxicology, and Pharmacokinetic Services

The scope of this Task Order is to perform preclinical safety, toxicity and pharmacokinetic studies of interventional agent candidates against in vitro, or in relevant small and large animal models.